INITIAL INTRACELLULAR EVENTS OF STEROID HORMONE ACTION

The objective of this project is to define the initial, intracellular events of glucocorticoid hormone action and steroid hormone action in general. Such studies are of particular current relevance since steroid hormone receptors are arguably the best understood regulators of eukaryotic gene transcription. The first step of steroid binding to the intracellular receptor is followed by activation of the receptor-steroid complex to DNA/nuclear-binding species that then associates with those nuclear acceptor sites involved in the regulation of transcription of selected genes in specific cells. The thiol groups of glucocorticoid receptors have been proposed to be important determinants of receptor activity and to form complexes with molybdate, which stabilize steroid binding activity and block activation of the receptor-steroid complexes. Nevertheless, we found that thiol groups are not required for the actions of molybdate or of the related metal oxyanions tungstate and vanadate. Likewise, although exogenous thiol-specific agents do alter receptor properties, the structural and functional changes of native glucocorticoid receptors that are associated with steroid binding, activation, and dissociation of heat shock protein 90, were found not to require the thiols of receptor protein. Furthermore, the tertiary structure of the receptor appears to be constituted in a manner that prevents the usually facile rearrangements of any disulfide bond- containing structures that might form. One component that did have a major effect on glucocorticoid receptors was a low molecular weight factor(s) that was previously determined to be required for the DNA binding of a sub-population of activated complexes. We have now found that this factor(s) equally affects the glucocorticoid receptors bound by agonists and antagonists and both progesterone and estrogen receptor complexes. Thus, factor-assisted DNA binding may be a general mechanism for all of the classical steroid receptors, which would offer an intriguing level of control for steroid regulated gene expression. Collectively, our current findings contribute to our long term goal of defining the mechanisms of steroid hormone action at a molecular level.